Chronic and Evolving Inflammation after Traumatic Brain Injury: Microglial Priming and Neuropsychiatric Complications

PROJECT SUMMARY/ABSTRACT:
Traumatic brain injury (TBI) can lead to significant neuropsychiatric problems and neurodegenerative pathologies
that develop with time after injury. These issues may be propagated by neuroinflammatory processes that
continue well after the initial injury. Pt.3 We have reported that diffuse TBI in mice leads to “microglial priming”
within cortical and hippocampal regions, in which the microglia remain in a sensitized state and are highly
inflammatory following an immune challenge 30 days post injury (30 dpi). In this application, we show a distinct
phase transition from acute (8-24 h) to sub-acute (7 d) and then to chronic (30 d) cortical-inflammation/microglia
priming after TBI. Acutely, there was an inflammatory response after TBI that evolved into a subacute phase 7
dpi that was dominated by interferon (IFN) type I signaling. IFN responses are activated by cell distress and
damage to promote an immune response that can prime innate immune cells, including microglia. We provide
evidence of cortical neuronal damage 7 dpi with corresponding microglial activation. Pts.3&6 Single cell RNA
seq (scRNAseq) of the cortex 7 dpi shows unique clusters of microglia, trauma-associated, that are influenced
by IFNs. These microglia are involved in dendritic remodeling and suppression of neuronal homeostasis. At 30
dpi, there was cognitive impairment (associated with HPC & CTX), reduced network connectivity, and increased
immune reactivity of primed microglia. Microglia are critical in these processes because microglial elimination
(CSF1R antagonist) prevented TBI-induced neuroinflammation and IFN signaling, attenuated dendritic atrophy,
and improved network connectivity. Thus, we hypothesize that increased interferon signaling is critical in
promoting microglial priming and chronic neuroinflammation, dendritic remodeling, and cognitive decline. To
address this, three aims are proposed using a midline fluid percussion injury in mice. In Aim-1, we will eliminate
microglia to determine the influence of microglia on other CNS cells in the cortex and hippocampus acutely, sub-
acutely, and chronically after TBI. ScRNAseq will be used to determine the transcriptome signature of microglia
over time and in parallel with astrocytes, oligodendrocytes, and neurons at 3 these critical times after TBI. The
focus will be determining which cells express IFNs and IFN receptors, and how they respond to increased IFN
signaling with TBI. In Aim-2, we will determine if IFN signaling is critical in chronic neuroinflammation, pathology,
cognitive decline, and microglial priming after TBI. Here, we will attenuate IFN signaling at the levels of IFN-a/b
receptor activation (IFNαRKO, Mgl-IFNαRKO) and IFN production (STINGKO) to determine the extent to which
these interventions ameliorate neuroinflammation, pathology, and microglial priming. In Aim-3, we will determine
if TBI-induced microglial priming, chronic neuroinflammation, and cognitive decline 30 dpi are reversed by forced
microglia turnover. We will remove microglia (CSF1R antagonist) when IFN responses are highest 7 dpi, and
allow for microglial repopulation to 30 dpi. Completion of these aims will provide new insight on the IFN pathway
that appears to be critical in the transition from acute to chronic inflammation mediated by microglia after TBI.

Public health relevance
PROJECT NARRATIVE: Neuropsychiatric complications including depression and cognitive decline develop, persist, and even worsen in the years after traumatic brain injury (TBI), negatively affecting the quality of life and lifespan. Mounting evidence indicates that chronic inflammatory processes are active, but the mechanism that drives this response is unclear. Based on our collective data, we hypothesize that increased type I interferon signaling is critical in promoting microglial priming and the subsequent transition from acute inflammation to chronic neuroinflammation after TBI. Therefore, we will use strategies to characterize cell specific responses to TBI, attenuate interferon signaling, and force the turnover of microglia to protect against TBI-induced microglia priming, chronic neuroinflammation, and cognitive impairment.